CSHL Quantitative Imaging: From Acquisition to Analysis Course

Project Description or Abstract
Cancer is a highly heterogeneous disease, and the development of successful treatment
strategies requires an understanding of the cellular mechanisms that result in diversity of cancer
cell dynamics and interactions with the tissue environment. Quantitative imaging is a powerful
tool for understanding these cellular mechanisms. New quantitative imaging methods, including
light sheet microscopy, super-resolution microscopy and machine learning approaches to
biological image analysis, have enabled previously impossible experiments. Proper training in
the fundamental principles of quantitative imaging is essential to generating reliable data,
correctly interpreting experiments, and enhancing the reproducibility of cancer research. The
Cold Spring Harbor Laboratory proposes to continue the course “Quantitative Imaging: From
Acquisition to Analysis”, to be held in the spring of 2021-2025. This two-week intensive course
provides students with a thorough foundation in state-of-the-art quantitative light microscopy
and image analysis techniques. The course is designed to engage a multidisciplinary audience,
including biologists, physicists, engineers and computer scientists at all career stages, from
graduate student to Principal Investigator. A unique aspect of this course is its strong emphasis
on generating accurate and precise quantitative imaging data. A typical day of the course
includes didactic lectures, a research seminar, a group discussion session and focused
quantitative imaging laboratory exercises. The exercises include both image acquisition and
analysis, and are planned such that, over the duration of the course, the most common types of
quantitative measurements used in cancer research are covered, including: co-localization,
measurement of fluorescence intensities, live specimen imaging,3D-image analysis, and
detection/tracking/counting of diffraction-limited objects, subcellular structures, and whole cells.
Students learn to use a wide range of imaging modalities to complete the exercises, including
widefield fluorescence, point-scanning and spinning disk confocal, total internal reflection
fluorescence, light sheet and super-resolution microscopy. A suite of computers equipped with
free open-source software are used to process data and make measurements using modern
image analysis methods, including machine learning approaches. In the daily group discussion,
students present and discuss their results with the course instructors, thereby developing
expertise in assessing the quality of quantitative measurements and critical troubleshooting
skills. The instructors are internationally recognized leaders in quantitative microscopy and
computational image analysis, and invited seminar speakers provide examples of expert use of
quantitative imaging to answer biological questions. Quantitative Imaging: From Acquisition to
Analysis provides training in quantitative microscopy that is crucial for advancing the mission of
the NCI.

Public health relevance
Lay Summary The rapid ongoing development of novel imaging methods and tools is opening new directions for study in the field of cancer biology. The primary objective of the two-week course "Quantitative Imaging: From Acquisition to Analysis" is to train research scientists in the fundamental principles of quantitative light microscopy and computational analysis of biological images. The course offers lectures, discussion groups and extensive hands-on laboratory work using a wide range of conventional, advanced and emerging imaging techniques, and is designed to engage a multidisciplinary audience, including biologists, physicists, engineers and computer scientists. The short intensive nature of the course enables scientists to immerse in the concepts and techniques being taught and then rapidly disseminate what they have learned to others in their own laboratories.